DETERMINATION OF THE INFECTIOUS DOSE OF NORWALK VIRUS IN HUMAN VOLUNTEERS

The main objective is this study is to determine the dose response range of Norwalk virus (NV) infectivity in adult human volunteers. This will in turn enable us to establish the risk of NV infection.